Mechanisms of Gastrointestinal COVID-19

Project Summary
Although coronavirus disease 2019 (COVID-19) is primarily defined as a respiratory illness, patients often
experience clinical gastrointestinal symptoms, including abdominal pain and diarrhea. We recently found that
severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), the virus that causes COVID-19, infects and
replicates in human small bowel intestinal epithelial cells (IECs). However, the molecular mechanisms of SARS-
CoV-2 driving gastrointestinal pathology, particularly in vulnerable populations with preexisting diseases remain
unclear.
In this proposal, our overall objectives are to better define the cellular signaling of SARS-CoV-2 interactions
with IECs, enteric immune responses, and microbiome in the context of health or inflammatory bowel disease
(IBD). Our preliminary data suggest that compared to normal COVID-19 patients, those with IBD have higher
expression of cathepsin L in IECs, which correlated with higher viral loads. Our central hypothesis is that SARS-
CoV-2 induces a distinctive intestinal pathology and mucosal immune response that is shaped by host factors
(IBD), luminal factors (secretions, bile salts, and microbiome), and therapeutics (mesalamine). Specifically, using
healthy and IBD-derived organoids, COVID-19 patient fecal samples, and K18-hACE2 mice, we aim to (1) define
the host factors and cellular mechanisms involved in SARS-CoV-2 infection of normal and IBD epithelium, (2)
determine the impact of intestinal SARS-CoV-2 infection on intestinal immune response and colitis, and (3)
define the environmental factors that influence intestinal infection with SARS-CoV-2.
With extensive and collaborative expertise in IBD, virology, and host-microbial interactions, we expect to
address mechanistically interesting and clinically important questions like “What is the intestinal pathogenicity of
SARS-CoV-2 and how is it impacted by IBD?”, “What is the interaction of SARS-CoV-2/COVID-19 with intestinal
inflammation and IBD therapies?”, and “What is the impact of intestinal contents and IBD diagnosis/microbiome
on intestinal SARS-CoV-2?”. We anticipate that this pathology will further our understanding of SARS-CoV-2
interactions with the epithelial and immune cells to explain COVID-19 GI symptoms with or without IBD. We also
expect the new information gained from this project will expand our understanding of acute gastrointestinal
pathology and symptoms of COVID-19, provide mechanistic context to existing clinical and translational literature,
and create a foundational knowledge and tool set for deeper investigations into COVID-19 and potentially
pathogenic and emerging coronaviruses of the future.

Public health relevance
Project Narrative Coronavirus disease 2019 (COVID-19) has infected millions, impacted billions of lives, and precipitated socioeconomic destabilization. There is a pressing need to understand how the COVID-19 causing virus, SARS- CoV-2, drives intestinal disease and furthermore whether and how it may interact with underlying gastrointestinal disease including the inflammatory bowel diseases.